Engineering nanowired cardiac organoids for cardiac regeneration

Project Summary: Cardiovascular diseases (CVDs) such as myocardial ischemia/reperfusion (I/R) injury lead
to extensive cardiomyocyte death and subsequent reduced cardiac function. Due to the human adult heart’s
limited regenerative capacity, there is a significant need for exogenous cardiac function restoration post-I/R.
Human pluripotent stem cell-derived cardiomyocytes (hPSC-CMs) have emerged as a favorable cell source to
restore myocardial function. While promising, the therapeutic potential of hPSC-CM transplantation is hampered
by low cell survival and inadequate integration with host myocardium. Thus, our lab has developed nanowired
human cardiac organoids composed hPSC-CM, primary human adult cardiac fibroblasts, endothelial cells,
stromal cells, and electrically conductive silicon nanowires (e-SiNWs). Our in vivo data shows that organoids are
capable of robustly engrafting and providing functional recovery (69% Fractional Shortening recovery) in I/R
injured rat hearts, while using 10% of the cell dose (1E6, 1x106 cells/rat) that other hPSC-CM transplantation
studies used (1E7, 1x107 cells/rat). Additionally, to alleviate major histocompatibility class (MHC) mismatching to
provide a translational platform for hPSC-CM delivery, our lab developed isogenic cardiac organoids,
composed of hPSC-CMs, -cardiac fibroblasts (hPSC-cFBs), and -endothelial cells (hPSC-ECs) from a single
hiPSC cell line. The goals of this proposal are to 1) investigate the impact of e-SiNW geometry on isogenic
organoid function, and 2) demonstrate the therapeutic efficacy of optimized nanowired isogenic cardiac
organoids in a rat I/R injury model. The central hypothesis of this proposal is that engineered nanowire
surface geometry will enhance interactions between host myocardium and transplanted hPSC-CMs within
isogenic cardiac organoids, resulting in efficient engraftment and significant functional recovery. The
innovation of this proposal is engineering e-SiNW surface roughness to optimize the efficiency of myocardial
engraftment, and thus the functional recovery of I/R-injured hearts. My long-term goal is to leverage
translational engineering and informatics to develop a clinically viable cardiac cell therapy heart repair.
Accordingly, we will pursue the following two aims: 1) investigate the effects of e-SiNW geometry on isogenic
cardiac organoid function, and 2) determine the therapeutic efficacy of optimized nanowired isogenic cardiac
organoids to treat I/R-injured rat hearts and investigate e-SiNW graft-host interactions using spatial
transcriptomics. The proposed research would provide a translational platform for cardiac repair with efficient
engraftment.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the leading cause of death worldwide. The goal of this proposal is to investigate the bioelectric interface of electrically conductive silicon nanowires and isogenic cardiac organoids to provide an efficient platform to alleviate cardiovascular disease burden.